Impact of neighborhood and workforce deprivation on diabetes outcomes in Veterans: a spatio-temporal analysis

Anticipated Impacts on Veterans Health Care: This project will put forth a comprehensive geospatial
framework to address the VA Blueprint for Excellence Strategy 3: Leverage information technologies,
analytics, and models of healthcare to optimize individual well-being and population health outcomes.
By creating a spatially referenced dataset incorporating health information, workforce productivity,
neighborhood deprivation, we will develop a comprehensive database to examine multiple dimensions of
diabetes care. Through the use of advanced GIS and spatiotemporal statistics, we will identify hotspots of high
disease risk, poor neighborhood resources, and low VA workforce capacity. This information will improve
access to care by helping VA policy makers better match resources to areas with poor outcomes. Finally, by
pinpointing areas with excessive health expenditures, the VA can develop cost-reduction measures to improve
Veterans’ health while containing costs.
Background: Diabetes is the seventh leading cause of death in the United States, can lead to serious
complications, and is associated with increased healthcare costs. Prevalence estimates for Veterans show a
disproportionate burden of disease, with estimates close to 25%, as compared to 8% of the general US
population. Evidence consistently shows racial minorities have a higher prevalence of diabetes, worse
outcomes, higher risk of complications, and higher mortality rate compared to non-Hispanic whites. This
disparity persists after controlling for patient-level factors such as education, income, knowledge, health
literacy, and self-efficacy; provider-level factors, such as bias, communication, and trust; and system-level
factors, such as access to care. Little attention has been given to differences that may be explained by regional
variation in patient-level resources, community-level resources, and health workforce resources.
Objectives: This study seeks to identify and explain spatial and temporal variation in health outcomes,
community resources, VA workforce capacity, and health disparities among patients with type 2 diabetes. Aim
1 will examine spatiotemporal trends in diabetes outcomes, including metabolic control, cost, and mortality.
Aim 2 will develop a new spatiotemporal neighborhood deprivation index and examine its association with
diabetes outcomes and racial disparities. Aim 3 will develop and validate a novel geographic workforce
deprivation index to examine its association with diabetes outcomes and racial disparities.
Methods: We will construct a cohort of veterans with type 2 diabetes receiving either inpatient or outpatient
care at the VA during the years 2000 through 2015 by linking multiple patient and administrative files from the
VHA National Patient Care and Pharmacy Benefits Management databases, using a previously validated VA
algorithm. Using advanced GIS and spatial statistical methods, we will examine spatiotemporal trends in
diabetes outcomes among Veterans with type 2 diabetes. In Aim 1, we will develop a flexible Bayesian
spatiotemporal model to identify hotspots of high prevalence of diabetes-related outcomes. In Aims 2 and 3,
we will use spatiotemporal latent factor models to develop novel neighborhood and workforce deprivation
indices, allowing us to investigate evolving patterns in community resource availability and VA workforce
capacity. Completion of these aims will enable the VA to identify individual, community, and institutional factors
associated with poor diabetes outcomes and to target community and system-level efforts to improve health in
low-resource areas.

Public health relevance
Understanding variation in access to healthcare and the physician workforce will provide actionable information on strategies to address disparities by providing targets for policy-level interventions. This application will use advanced GIS and spatial statistical methods to examine spatiotemporal patterns and identify persistent hotspots of poor outcomes, increased utilization and cost, and increased mortality in patients with diabetes across the VA healthcare system. We will leverage our expertise in diabetes care, equity research, GIS analysis, and advanced spatiotemporal statistics to (1) create a comprehensive and unique database, (2) create a workforce deprivation index that allows incorporation of variation in the physician workforce into policy decisions, and (3) incorporate neighborhood/community factors to inform VA policy to improve Veteran health. This innovative methodology will be applicable across disease states, and once developed can be disseminated to better target systems engineering and intervention development efforts.